Regulation of innate antiviral responses by the DNA-binding transcriptional repressor complex CIC-ATXN1/L

Abstract
Interferon (IFN) and IFN stimulated genes (ISGs) are a critical component of innate immune responses that help
in the early control of viral infections. Transcriptional upregulation of IFN and ISGs is tightly controlled through
negative regulators under basal conditions to maintain homeostasis, as aberrant expression of IFN and ISGs
can promote diseases like chronic viral infection, cancers, neurodegeneration, and diabetes. Through a genome-
wide CRISPR/Cas9 screen to identify proviral host factors and regulators of innate immunity, we identified
Capicua (CIC) as a novel regulator of innate immune responses, as CIC knockout (CIC KO) cells demonstrated
transcriptional upregulation of IFN and ISGs under basal conditions and showed restricted replication of different
RNA viruses. Based on studies in drosophila and cancer models, CIC, a highly conserved DNA-binding
transcriptional repressor, binds to a specific octameric sequence (CIC binding site or CBS) near target genes
and constitutively represses gene transcription. Through promoter motif analysis of ISGs upregulated in CIC KO
cells identified by RNA-Seq, we observed the presence of CBS motifs in several, but not all, upregulated ISGs,
including RIG-I, MDA-5, IRF3/7/9, IFNβ, IFNγ, IFIT1, TRIM22, MX1, and ISG15. Preliminary Assay for
Transposase-Accessible Chromatin (ATAC)-Seq analysis confirmed increased chromatin accessibility near the
putative CBS containing IFIT1 and TRIM22 promoters in CIC KO as compared to control A549 cells. In addition,
we validated direct CIC binding to IFNβ and ISG promoters (STAT1, IFIT1,TRIM22) by chromatin
immunoprecipitation-qPCR (ChIP-qPCR) analysis. Moreover, the CIC-ATXN1/L co-repressor complex is rapidly
degraded during influenza virus infection, suggesting that degradation of the CIC-ATXN1/L complex may be an
integral part of the innate immune response pathway. Importantly, the innate immune regulatory function of the
Cic-Atxn1/l co-repressor complex is conserved in the murine model. Based on these findings, we propose a
novel model for the transcriptional regulation of IFN and ISGs: under basal conditions, the CIC-ATXN1/L co-
repressor complex binds to CBS and represses ISG transcription; however, virus-induced proteasomal
degradation of CIC-ATXN1/L relieves these target genes from active repression, thereby allowing for robust
transcription through IRFs and STATs. The goal of this proposal is to gain mechanistic insights into the
transcriptional regulation of IFN and ISG promoters by the CIC-ATXN1/L co-repressor complex, ultimately
providing a new paradigm for the regulation of cell autonomous antiviral responses.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Narrative Several human illnesses such as chronic viral infection, cancer, autoimmunity, and neurodegenerative diseases are due to aberrant activation of innate immune responses and are associated with production of proinflammatory cytokines. We have identified a novel repressor complex composed of Capicua-Ataxin1 or 1L, which prevents aberrant expression of antiviral genes in the absence of virus infection; and, upon viral infection, this complex is rapidly degraded to turn on antiviral responses. Our proposed study will investigate the Capicua-Ataxin1 mediated regulation of innate immune responses in human cells and knock out mouse models.